Fully Realizing Pangenomics Alignment

PROJECT ABSTRACT
Read aligners first build an index from one or more reference genome(s) and subsequently use it to find and
extend matched subsequences between sequence reads and the reference(s). The bottleneck of using these
read aligners to index thousands of human reference genomes is the space and time needed for construct
and store the index. Hence, in the case of the human genome, it is common to restrict interest to alignment of
the standard reference genome, i.e., GChr38. Yet, the absence of diversity in this single reference genome
can cause substandard results in downstream analysis, impacting the ability to identify and study genetic
variation.
To address the shortcomings associated with using a single reference genome, the concept of a pange-
nomics reference genome has been introduced and adopted. For example, Giraffe, VG, and Moni all aim
to index a population of genomes in a manner that enables read alignment. Although, these pangenomics
aligners have been shown to improve on the accuracy over standard read aligners (e.g., BWA and Bowtie)
there exists several challenges that prevent these methods from being used in practice for downstream anal-
ysis, such as variant calling. The goal of this proposal is to develop algorithms to address these challenges
and fully enable pangenomics alignment. In particular, we will create methods for selecting (from a large
population) a subset genomes that will achieve the most accurate alignment results, develop a pangenomics
scoring scheme that will enable the alignments from a pangenome to be attained, and disseminate our
methods in a user-friendly manner that enables automated updates.

Public health relevance
PROJECT NARRATIVE This research will develop the means to build a pangenomic reference genome, which will be applied in order to construct a novel human reference genome that encapsulates variation within the population. This will, in turn, facilitate the study of complex traits and diseases that require the use of a multifactorial, high-quality reference genome. Examples of such diseases and traits include cancer sub-types, autism, schizophrenia, and Parkinson’s disease.